INSTRUMENT FOR REAL TIME RENAL MONITORING

The mortality rate for acute renal failure has not changed significantly during the last 25 years. This may be due in part, to the inability to adequately predict and identify the onset and causes of acute renal failure. Current measurement techniques cannot quickly identify changes in renal function; the time for measuring renal function is typically four hours. An accurate means for measuring renal function in real time (i.e.,measuring and seeing changes in renal function as they occur) should allow researchers to better understand the pathophysiology of acute renal failure and lead to significant reductions in mortality rate and in the number of persons requiring acute dialysis associated with acute renal failure. The goal of this proposal is: 1) to complete development of an instrument for measuring renal function in real time and 2) to validate the measurement accuracy and the response time for rapid changes in renal function. Making this instrument available to nephrologists should allow researchers to demonstrate the efficacy of real time renal monitoring in saving lives and reducing the number of those who require acute dialysis. This may lead to real-time renal monitoring of most intensive care and organ transplant patient. PROPOSED COMMERCIAL APPLICATION: The commercial motivation for this project is two fold. 1) the cost benefit to patients and healthcare providers derived from less time in Icu and from reducing the number of persons permanently needing dialysis and 2) commercial sales of renal monitors for use in ICU' s worldwide. Annual commercial sales should exceed $10 million, and savings in healthcare costs should be even greater.